An Investigation of the Neighborhood Density of Cannabis Outlets and its Effect on Traffic Crashes

Project Summary
In the past decade, fatal traffic crashes involving cannabis have doubled in the United States (US). This trend
is associated with state policies that expand access to adult use of cannabis through the legal market. There is
a societal need for a) examination into local cannabis policy, the ensuing neighborhood density of cannabis
outlets, and their relationship to social determinants of health and traffic crashes; and b) investigators who are
trained to execute such research and translate findings into public health action. The applicant, a doctoral
candidate in epidemiology at Michigan State University, leverages his interdisciplinary mentorship team of
experts, optimal training environment, and injury prevention research experience to propose this predoctoral
fellowship that will address these needs. Firstly, this research aims to 1) describe spatial associations between
census tract cannabis outlet density and social determinants of health (e.g., alcohol outlet co-location and
community deprivation); 2) estimate the spatiotemporal relationship between census tract cannabis outlet
density and traffic crashes; and 3) estimate the effect that municipality-level policies permitting the operation of
adult-use cannabis outlets have on traffic crashes. To complete these aims, the applicant will complete the
creation of a novel spatiotemporal dataset that aggregates publicly available cannabis outlet and traffic crash
data within Michigan, the first state in the Midwest region of the US to legalize adult-use of cannabis. This
research will implement innovative spatiotemporal and econometric modeling. Successful completion of these
aims will inform NIDA’s priority research objectives (NOT-DA-22-003) and focus area goals (1.2) regarding the
impact that local cannabis policy has on public health. Moreso, this research is formally supported by the State
of Michigan Office of Highway and Safety Planning (MOHSP). Project results will be directly communicated to
MOHSP and will have an immediate impact on local, state, and national cannabis policy making. Secondly, this
fellowship’s comprehensive training plan will facilitate the applicant’s long-term career goal of becoming an
independent substance use and injury science epidemiologist with expertise in the nascent cannabis regulatory
environment. Through formal coursework, workshops, seminars, conference presentations, and structured
mentorship, the applicant will cultivate an interdisciplinary methodological toolkit, gaining essential skills in
substance use and spatial epidemiology, injury prevention science, policy evaluation through econometrics,
and professional development. The advising team comprises substantive experts in cannabis use epidemiology
(Dr. Kipling Bohnert, Proposal Sponsor), injury prevention (Drs. Jason Goldstick and Christopher Morrison),
geography (Dr. Richard Sadler), policy evaluation (Dr. Claire Margerison), traffic crash research (Dr. Morrison),
and spatiotemporal statistics (Drs. Goldstick, Sadler, and Morrison). This fellowship will effectively prepare the
applicant, Matthew Myers, for a career as an independent substance use and injury prevention epidemiologist
and will establish an evidence base used to prioritize public health in cannabis-related policy making.

Public health relevance
Project Narrative Given the current changes in cannabis policies between and within states, cannabis availability (i.e., cannabis outlet density) is heterogenous at a local level and is an emerging modifiable factor to potentially reduce injury and to broadly improve public health. Conclusions drawn from this work will directly contribute to evidence- driven cannabis policy making by 1) illuminating the extent to which the locations of cannabis outlets are associated with traffic crashes and 2) by providing an evidence base for more equitable cannabis policy making that prioritizes public health. Further, the applicant has aggregated spatiotemporal data of cannabis outlet locations in Michigan; this data can be used in their future epidemiological efforts that will examine the relationships between the commercial cannabis landscape and public health outcomes.